Adaptive high-resolution electrical stimulation for retinal implant design

Project Summary/Abstract
The goal of our work is to develop a high-resolution electronic epiretinal implant for treating
incurable blindness from retinal degeneration. To further this goal, we propose here to develop
novel techniques for adaptive, high-resolution, multi-electrode recording and stimulation of
retinal ganglion cells (RGCs) in the isolated macaque and human retina as an experimental lab
prototype for the future device. The major goals of this project are to (1) adaptively use current
steering with electrode triplets to enhance selective targeting of RGCs, (2) adaptively use
spatio-temporal dithering and multiplexing to produce naturalistic activity in large RGC
populations that can support high-quality visual coding, and (3) test the fidelity of electrically
evoked visual signals in RGCs of the central human retina. Tackling these aims will allow us to
emulate the neural code for vision, cell-by-cell and spike-by-spike, over a region of the central
retina. Our unique technical approach involves large-scale, high-resolution electrical recording
and stimulation, combined with novel computational approaches to adjust device function to the
complex circuitry in which it is embedded, including the degenerated retina, and thus to optimize
vision restoration.

Public health relevance
Project Narrative The goal of the proposed work is to substantially enhance the function of electronic retinal implants for treating incurable blindness. We use electrical recordings and stimulation of the isolated macaque and human retina as an experimental lab prototype for this future device, and use it to develop ways to efficiently interface with the neural circuitry of the retina and provide it with high-fidelity artificial visual signals. This research will advance the design of the next generation of retinal implants, to support advanced visual functions such as object recognition and navigation.